LHRHA TO STUDY THE PUBERTAL PROCESS

The goal of the study is to examine the effects of LHRHa induced pituitary desensitization upon its process of puberty. We will compare the status of two populations prior to and following treatment. The two populations are: 1) subjects undergoing normal puberty who are GH deficient, 2) subjects with central precocious puberty.